RR&D Research Career Scientist Award Application

Linda Resnik’s research links the fields of rehabilitation and health services research, focusing on three areas:
1) design and evaluation of upper limb prosthetic devices; 2) development, evaluation, and deployment of
rehabilitation outcomes measures; 3) study of delivery and effectiveness of rehabilitation services. The
overarching goal of her research is to improve the quality of rehabilitation care for persons with chronic and
disabling conditions. Dr. Resnik has been evaluating prosthetic technology since 2009. She was Principal
Investigator of the VA Study to Optimize the DEKA Arm and led VA efforts to evaluate the DEKA Arm and
transition it to clinical practice. From 2016-2022, she led a national study that compared function, satisfaction,
and quality of life for prosthesis users and non-users, compared outcomes by sex, prosthesis, and terminal
device type. She currently leads a related study that is collecting data to enable more robust comparisons by
prosthesis type and quantify the impact of prosthesis features. She collaborated on the first home trials of a
neural connected sensory prosthesis stud and is site PI for the clinical trial, Peripheral Interfaces in Amputees
for Sensorimotor Integration (Tyler, PI). Dr. Resnik developed and validated three new activity performance
measures for upper limb amputees and developed a briefer version of the Southampton Hand Assessment
(SHAP) measure. She has developed and/or refined numerous self-report measures for use upper limb
amputation care producing: a modified TAPES psychosocial adjustment scale, a prosthesis satisfaction
measure responsive to the concerns of women, a modified PROMIS-UE short form with amputation-specific
calibration, a physical function measure for prosthesis users (UEFS-P), a residual limb health scale, and new
measures of prosthesis experience, prosthesis affordability and prosthesis acceptance Her new VA Merit
Review, Advancing measurement of physical function in upper limb amputation will expand on her work in
measurement of physical function and develop clinical translation tools to facilitate measure adoption. Dr
Resnik also developed measures of Veteran community integration using the conceptual framework of
“participation” as described by the WHO’s International Classification of Functioning, Disability and Health, the
Community Reintegration of Injured Service Members (CRIS) and the CRIS-CAT a computer adaptive test
version of the measure. Dr. Resnik is the PI of two centers; LeaRRn: the Learning Health Systems
Rehabilitation Research Network and CoHSTAR: the Center for Health Services, Research and Training. Both
centers train rehabilitation researchers in health services and translational research. Dr Resnik mentors
trainees and collaborate on studies of rehabilitation services (e.g., examining outcomes after traumatic brain
injury; comparing effectiveness of post-acute rehabilitation; and policy impact. Her earlier work explored factors
associated with effective rehabilitation care delivery , advanced risk adjustment methodology, and explored
provider benchmarking

Public health relevance
Linda Resnik is a physical therapist researcher whose work links the fields of rehabilitation and health services research. She focuses on three research areas: 1) design and evaluation of upper limb prosthetic devices; 2) development, evaluation, and deployment of rehabilitation outcomes measures; 3) study of delivery and effectiveness of rehabilitation services. Her research involves extensive relationships with clinician scientists, investigators, and VA clinical program leaders to maximize dissemination and implementation of findings.